Age-related impairment in anti-HMGB1 IgM response potentiates type 2 diabetes

PROJECT SUMMARY
Type 2 diabetes (T2D) is a common disease in older adults and also a risk factor for other age-related
diseases. A common link of these diseases is age-related increase in low-grade chronic inflammation (known
as “inflammaging”). Chronic inflammation is triggered partly by damage-associated molecular patterns
(DAMPs). HMGB1 (High-Mobility Group Box 1) is a prototypical DAMP that is evolutionarily conserved, and it
is implicated in the pathogenesis of several age-related diseases including T2D and cardiovascular disease
(CVD). Recently, in both normal mice and healthy human blood donors, we identified an endogenous anti-
HMGB1 IgM antibody (Ab) that neutralizes the proinflammatory activity of HMGB1, via binding to a highly
conserved epitope of HMGB1, namely HMW4. This anti-HMW4 IgM was upregulated in mice in response to
challenge with high fat diet (HFD). Critically, the ability to upregulate anti-HMW4 IgM (upon HFD challenge)
was impaired in middle-aged (9-month-old) male and older (14-month-old) female mice, which correlated with
the increase in vulnerability (or decrease in tolerance) to the diabetogenic effect of HFD, as reflected by more
rapid onset of insulin resistance (IR). These data compel us now to test our hypothesis that anti-HMW4 IgM
plays a diabeto-protective role, and the age-related impairment in raising this IgM represents one of the factors
contributing to the increase in vulnerability to the diabetogenic effect of HFD and, thus, the risk of IR/T2D.
We propose two specific aims. Specific Aim #1 is to determine whether anti-HMW4 IgM is diabeto-
protective. We will use two complementary approaches: 1) Determining whether infusion of anti-HMW4 IgM
into young, middle-aged, and age mice (“gain-of-function”) confers protection against HFD-induced IR and
inflammation. 2) Determining whether diminishing this IgM response by depletion of anti-HMW4 IgM-producing
B-1 cells in young mice (“loss-of-function”) impairs their tolerance to HFD. Specific Aim #2 is to identify age-
related defects in HMW4-reactive B-1 cells that impair the anti-HMW4 IgM response, with the focus on the
TLR4 signaling axis. We will use two approaches: 1) Analyzing TLR4 activation in peritoneal HMW4-reactive
B-1 cells from young, middle-aged, and aged mice to determine whether middle-aged and aged mice have a
defect in TLR4 signaling. 2) Treating middle-aged and aged mice with the TLR4 agonist MPLA to determine
whether enhanced TLR4 stimulation restores their anti-HMW4 IgM response and tolerance to HFD.
The significance of our studies lies in a few aspects. The studies will identify an age-related
mechanism for regulating chronic inflammation and the body’s tolerance to fatty foods. They will provide
valuable insight into the immune-metabolic interplay in metabolic challenge. They are expected to yield a novel
target for immunotherapy (i.e., anti-HMW4 IgM-producing B cells) and an “injectable” therapeutic (i.e., anti-
HMW4 IgM) for age-related diseases including T2D and CVD.

Public health relevance
PROJECT NARRATIVE This project aims to evaluate a hypothesis that our body produces an anti-inflammatory antibody in response to ingestion of high-fat food, and that impairment in producing this antibody in older adults increases their vulnerability to proinflammatory, diabetogenic effect of high-fat food and, thus, the risk of type 2 diabetes (T2D). Completion of this project will not only generate insights into the immune mechanisms regulating age- related chronic inflammation and tolerance of the body to metabolic challenge of high-fat food, but also lead to the development of a novel therapeutic for treating T2D and other age-related diseases.